Functional connectivity associated with motor recovery after internal capsule lesions

Project Summary
Stroke survivors face significant long-term health consequences, with rehabilitation being essential to improve
their recovery and quality of life. Currently, patients who do not restore motor function after 3-6 months are
unlikely to show further recovery. Lesions with white matter tract involvement typically correlate with worse
outcomes. For example, corticospinal tract lesions (CST) lesions produce worse motor deficiencies and portend
poor functional recovery. Brain-computer interface mediated stroke rehabilitation (BCI-SR) can be a powerful
rehabilitation tool. In BCI-SR, a patient learns to modulate localized brain activity that is recorded by electrodes.
This can be used to control an orthosis to move the paretic limb. Most BCI systems utilize signals from affected
hemisphere, attempting to drive plasticity in injured cortex. However, residual brain function after stroke limits
BCI-SR efficacy, making ipsilesional BCI difficult to use in patients with the worst injuries. In humans,
contralesional BCI-SR devices have used the uninjured hemisphere to drive further rehabilitation after the
traditional plateau in motor function recovery.
Clinical predictions of functional outcome after stroke are imprecise. Resting state functional connectivity (rsFC)
measures the correlation of blood oxygen level-depending (BOLD) fluctuations at rest across the brain, providing
a powerful tool to study brain network remodeling after stroke. However, human studies investigating brain
remodeling after a stroke typically include patients with diverse lesions and do not have access to baseline
measurements that allow rsFC comparison pre- and post-stroke. Animal studies could address both issues by
enabling the generation of replicable, homogenous, and specific infarcts and by allowing collection of baseline
measurements prior to infarct generation. There is also an absence of adequate animal studies characterizing
rsFC changes associated with BCI rehabilitation strategies.
Our project goal is to further characterize rsFC changes associated with CST lesions and test a BCI-mediated
rehabilitation strategy after motor recovery plateaus. We will generate uniform lesions in the CST of six Rhesus
macaques and after three months of natural recovery, drive contralesional BCI-SR. In each primate, we will
collect resting-state functional MRI at baseline before lesioning, after CST lesioning, and during contralesional
BCI-SR. We will then identify acute and chronic changes in rsFC that correspond with CST lesioning, innate
recovery, and brain-computer-interface mediated rehabilitation. Through these approaches, we seek to validate
the efficacy of a novel stroke rehabilitation strategy while providing insight into recovery-associated changes in
rsFC.

Public health relevance
Project Narrative Stroke survivors face significant long-term health consequences, with rehabilitation being essential to improve their recovery and quality of life. To explore changes in functional network organization after white matter lesions, we will collect resting-state functional MRI at baseline, after injury, and during a brain-computer-interface mediated rehabilitation. We will identify acute and chronic changes in resting state functional connectivity that correspond to the lesion, innate recovery, and brain-computer-interface mediated rehabilitation.